SMALL ANIMAL IMAGING RESEARCH PROGRAM

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. The Small Animal Imaging Research Program at UT Southwestern provides critical infrastructure to facilitate small animal cancer imaging. Since inception, the SW-SAIRP has supported imaging in five modalities- MRI, PET, bioluminescence, fluorescence, and [unreadable]-scintigraphy. As described below, these capabilities have been enhanced and expanded. SW-SAIRP investigators and support personnel advise on development of imaging protocols and optimal implementation of imaging investigations to enhance cancer research. Synthesis and radiolabeling are supported to generate materials not commercially available for imaging investigations. The experience of the investigators and availability of imaging infrastructure are designed to expand imaging opportunities for investigators at UT Southwestern and surrounding institutions, including academic centers and industry. New interactions are generated through an annual symposium, regular seminars, and participation in regional and international workshops and conferences. We have extensive experience in small animal research, tumor implantation, anesthesia and data evaluation. In addition, we can provide bioluminescence imaging to evaluate tumor growth. All five modalities are available and the MR components use the equipment within the Research Resource.